Circadian regulation of neocortex

Project Summary
Little is known about the mechanisms that determine daily rhythms in rest-activity. We recently
found that cells within the motor cortex can be synchronized to daily cycles of glucocorticoids.
We hypothesize that daily suprachiasmatic nucleus activity and corticosterone secretion entrain
circadian rhythms in cortical neurons and astrocytes to regulate daily patterns of behavior. We
will take advantage of new high-throughput, machine learning and the ability to record and
manipulate gene expression and calcium levels in specific cell types in mice. Combining these
methods with two-color, real-time imaging of gene expression simultaneously in neurons and
astrocytes, we will determine the roles of cortical neurons and glial in distinct daily activities.

Public health relevance
Project Narrative Daily rhythms in rest-activity are well-known, but it is unknown how they arise or synchronize to local time. Our preliminary data show that circadian rhythms intrinsic to motor cortex can be entrained in vivo and in vitro. We will test the roles of specific cells and molecules in producing daily rhythms in cortical neurons and astrocytes and in a variety of behaviors.